Engineering Smart Antibody-like Protein Scaffolds with precision switches

PROJECT SUMMARY / ABSTRACT
The goal of this Focused Technology R&D proposal is to develop and apply modular and generalizable
engineering approaches to generate smart antibody-like protein scaffolds (APSs) equipped with precision
switches, which can be controlled by light or drugs to confer remote control over endogenous proteins and
cellular physiology in multiple biological systems. Over the past decade, a variety of chemogenetic and
optogenetic tools have been designed to visualize, delocalize, modify, and degrade proteins of interest (POIs).
These engineering efforts, nonetheless, often require extensive prior knowledge on the targeted POIs. To
regulate endogenous POIs in living cells or organisms, one has to tag POIs with light- or chemical-sensitive
modules via genetic knock-in or genome engineering, thereby making the process rather time- and resource-
consuming. Furthermore, some of the existing chemo/optogenetic tools still suffer from relatively slow
activation kinetics, partial irreversibility, limited choices of chemoswitches , and narrow dynamic ranges of cue-
induced changes. To address these challenges, the transdisciplinary team proposes to engineer modular
precision switches into single-domain antibody-like protein scaffolds, rather than the endogenous target itself,
to confer tight control over POIs and the associated biological activities or pathways. Specially, the team will
combine seven selected APSs templates (including nanobody, monobody and affibody) with innovative
optogenetic and chemogenetic approaches to develop new generations of light- or chemical-controllable APSs
(named as LiAPSs and ChiAPSs, respectively). The prioritized choices of switches include: (i) photons
emitting in the blue, far-red, and near infrared (NIR) range (400-800 nm) to diversify the existing repertoire of
LiAPSs and significantly improve their kinetic and dynamic properties (Specific Aim 1); (ii) FDA-approved drugs
(antivirals) and beverages (caffeine and its metabolites) that promise to reduce barriers for translational
applications (Specific Aim 2). These switchable APSs will allow the team to remotely control antibody-antigen
recognition and to manipulate endogenous targets in a reversible manner at high temporal and/or spatial
resolution. In parallel, the team will demonstrate the applications of engineered smart APSs for acute and
precise initiation and termination of biological processes in cellulo, as well as remote in vivo immuno- or
neuromodulation in both rodent and Drosophila models of human diseases. Compelling preliminary data have
been provided to demonstrate the high feasibility of the proposed new approaches, as well as the team’s
mastery of the repertoire of methods, assays, and models described in the application. The innovative
molecular toolkit to be generated from the project will offer a wide choices of precision switches to enable
many future biological questions and impose a high and sustainable impact to the biomedical field.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT (PROJECT NARRATIVE) The proposed research is relevant to public health and the NIH’s mission of developing fundamental knowledge and therapeutics that will help reduce the enormous burdens of morbidity and mortality associated with human disease. The goal of this project is to develop new classes of engineered antibodies that can be precisely controlled to regulate cellular physiology. These smart antibodies can be used not only as broadly-applicable biomedical research tools, but also as potential precision therapeutics to intervene in human diseases, including cancer and neurodegenerative disorders.